Improving immune modulation for smoldering myeloma

Summary
All cases of multiple myeloma (MM) are preceded by precursor state termed as monoclonal gammopathy of
undetermined significance (MGUS). Therefore targeting precursor states may be an effective approach to
prevent this malignancy. In a recent randomized trial, we have shown that lenalidomide led to reduced risk of
progression of smoldering myeloma (SMM) to clinical myeloma. In prior studies, we have shown that the
immune system is capable of recognizing myeloma precursor lesions. In recent studies, we have also shown
that immune dysfunction is an early feature of myeloma suggesting that earlier application of immune
modulation may be needed to mediate immune prevention. In particular, evolution of clinical myeloma is
associated with attrition of stem-like memory T cells and the accumulation of terminally differentiated effector T
cells. In this proposal, we will test the hypothesis that immune control of myeloma precursor states is
determined in part by the cell states and spatial architecture of immune cells in these conditions. We further
posit that immune modulation to alter these properties could prevent evolution of clinical myeloma. This will be
evaluated with the following specific aims. In Aim 1, we will evaluate whether properties of immune cells at
baseline in SMM correlate with the risk of progression to clinical myeloma. Aim 2 will evaluate changes in
circulating and bone marrow immune cells in patients undergoing therapy with iberdomide or iberdomide and
dexamethasone under a randomized phase II clinical trial. Studies in aim 3 will evaluate the effect of immune
modulation on spatial heterogeneity of immune cells in preclinical model systems. Together, these studies will
not only provide new insights into improving immune modulation as a strategy to prevent clinical myeloma but
may also help develop novel immune based combinations to treat myeloma.

Public health relevance
Narrative: Studies under this project will evaluate clinical and preclinical aspects of immune modulation as a strategy to prevent clinical myeloma. These studies will involve both a clinical trial testing this approach as well as preclinical studies testing potential future combinations.